Mechanical Activation of Adipose-Derived Stem Cells for the Treatment of Diabetic Foot Ulcers Using a Novel CD-Microfluidic Device

Project Summary/Abstract The diabetic foot ulcer is the leading cause of nontraumatic lower limb amputations and carries the potential to dramatically affect the lives of 148 million individuals by the year 2035. The current standard of care includes physical offloading and surgical debridement, while newer allogeneic cell-based therapies are riddled with high costs and unpredictable outcomes. Emerging research has identified adipose-derived autologous stem cells as a potent therapeutic for safe and effective treatment of this lifestyle-limiting condition. Here, we propose a point-of-care closed system device that creates a “minimally manipulated” adipose tissue therapeutic that can then be reinjected back into the patient for the treatment of this lifestyle-debilitating complication, all in a matter of minutes. Our device incorporates a novel centrifugation platform and a unique microfluidic channel design that shears and stimulates inherent stem cell populations found in adipose tissue. This concept of shear-stress activation is of particular importance in the setting of diabetes due to the fact that diabetic adipose-derived stem cells exhibit greatly reduced function when compared to healthy adipose tissue. Additionally, our device carries significant potential for a precision medicine approach to creating autologous therapeutics, in that the amount of shear-stress applied by our device leads to dose-dependent increase in various stem cell markers and subpopulations. With this grant we will optimize the parameters of our device to generate a therapeutic that enriches and activates adipose-derived stem cell populations critical to diabetic wound healing. Once we identify the shear-stress that generates the highest proportion of regenerative populations while maximizing the safety profile of this tissue, we will test the stem cells in various culture conditions to demonstrate the mechanisms by which wound healing take place. Subsequently, we will examine this optimized therapeutic in an animal model to demonstrate the superiority of this enriched/activated therapeutic when compared to unprocessed adipose tissue from the same source. This study will generate sufficient in vitro and in vivo evidence that should propel us to a phase II study where we will further evaluate the safety and efficacy of the therapeutic generated by our device in various clinical models of diabetes. Our multidisciplinary team includes surgeons, biomedical engineers, business executives and regulatory experts that will significantly increase the likelihood of a successful product that adheres to the highest scientific, clinical and business standards upheld by the Food and Drug Administration.

Public health relevance
PROJECT NARRATIVE Diabetic foot ulcers are the leading cause of nontraumatic lower limb amputations due to the ineffectiveness of current treatments used, thus putting a tremendous cost to the healthcare system of $13 billion annually. This research proposal seeks to validate a proprietary novel CD-microfluidic device for the activation of adipose-derived stem cells for autologous treatment of this life debilitating condition. With the requested funds, we will be able to determine the optimal dosage for wound healing in order to bring this much needed treatment to market.